Multiphoton parallel Transmit for MRI

7. Project Summary/Abstract: Multiphoton parallel transmit for MRI
Magnetic Resonance Imaging (MRI) has been the undisputed standard of care for detecting and diagnosing
neurological disorders and injuries, and 7 Tesla MRI has repeatedly shown its potential for increasing contrast
and resolution. However, translation to the clinic has been hampered by the flip angle inhomogeneity problem
in high-field MRI. This results from wave interference effects that cause constructive interferences of the B1+
fields at the head's center and destructive interferences at the periphery. Perhaps the most promising
mitigation approach has been B1 shimming or full parallel transmit (pTx). However, a full pTx system adds
considerable costs (extra RF amplifier, cabling, and power monitoring equipment) as well as complicated the
estimation of local SAR, since maps of the electric field vector (E) for each channel must be known and
vectorially added to determine the total local electric field and, thus, SAR. The operator's confidence in the
local SAR predictions will depend on how well patient anatomy and positioning match the population of
numerical body models used to predict the electric fields. Additionally, the RF waveforms must be continuously
monitored during the scan to ensure they follow the prescribed waveforms. Lack of confidence in the local SAR
estimation procedure necessitates conservative power restrictions to ensure subject safety.
We address the hardware and SAR complications of pTx by introducing an excitation scheme that utilizes a
conventional birdcage RF coil, but achieves the benefits of conventional pTx by supplementing the excitation
with multiple low-frequency (kHz) transmitters placed around the head. We employ the multiphoton MR
phenomenon, which consists of an off-resonant excitation from a conventional birdcage coil together with low-
frequency, sinusoidal, localized, and spatially nonlinear variations in the z-directed magnetic field generated by
a multichannel shim array to shape the magnetization distribution. We formulate the multiphoton pulse
optimization problem in the small-tip regime to find multichannel shim array current amplitudes and phases that
substantially improve the transverse magnetization homogeneity in a brain region-of-interest (ROI). Using the
multiphoton phenomenon as a “correction” pulse following a conventional on-resonance birdcage excitation,
we generate highly uniform flip angle distributions that reduce the transverse magnetization magnitude
NRMSE over the brain four-fold compared to conventional birdcage excitation at 7 T in pulses that respect
gradient slew limits and have a total length of 1 ms. We will convert our shim array apparatus to provide the
needed z-directed oscillating fields and validate this approach for 7 Tesla brain imaging phantom and human
studies.

Public health relevance
Project Narrative (No more than 2 – 3 Sentences) Although higher field strength MRI scanners are more effective at evaluating brain disease and injury, their clinical use has been hampered by the difficulty of achieving a uniform image of the MR slice or volume. Our goal is to develop a novel approach called multi-photon excitation which offers the potential to safely solve this problem, facilitating the use of high field MRI in the clinic.